Imaging and Surgery Core

ABSTRACT – Core B
The imaging and surgical core will provide state-of-the-art imaging services to the program. Dr. Randolph’s
experience in organizing collaborative teams and her laboratory's background in macrophage biology and
lymphatic/vascular trafficking of immune cells and lipoproteins will facilitate applications in imaging that will be
tailored to the science of each project. The core will incorporate major contributions from highly expert co-
investigators. Dr. Bernd Zinselmeyer is an expert in multiple modalities of light microscopy, including its
application in studies of the CNS. He will contribute several lines of expertise in the grant, from confocal and 2-
photon microscopy to high-speed epifluorescence imaging. Dr. Song Hu is an innovator in photoacoustic imaging
with demonstrated expertise in using this technology to study the vasculature of the CNS. Dr. Igor Smirnov is an
expert microsurgeon who will provide and oversee highly skilled surgical manipulations for the projects, including
procedures like skull transplant and skull thinning. These co-investigators bring more than their state-of-the-art
expertise; they also all bring demonstrated collaborations with one or more project leaders. By working together,
this core team of investigators and affiliated staff will offer to all projects the following range of expert surgical
procedures and imaging applications. The aims of the imaging and surgical core are to (1) carry out deep-tissue
imaging of meninges and outer regions of the brain, (2) apply combinatorial methods (2-photon, high-speed
widefield, and photoacoustic imaging) for intravital imaging to investigate macrophage behavior and blood flow
dynamics in the meninges, and (3) employ established and novel tools to quantify molecular outflow from the
meningeal space.